Mapping Brain Lipid Architecture in Aging, LBD and T Cell Therapy using novel Imaging Mass Spectrometry

PROJECT SUMMARY
Dementia with Lewy bodies (LBD) and Parkinson's disease (PD) are characterized pathologically by the
presence of Lewy bodies, composed of misfolded alpha synuclein (α-syn) inclusions. These disorders are
progressive, and result in the degeneration of dopaminergic neurons in multiple motor and non-motor basal
ganglia circuits. There are no known disease altering drugs, hence there is an unmet need for delivering viable
treatments to slow down progression of LBDs. Furthermore, there is a growing body of literature suggesting the
role that lipids play in LBD pathogenesis. We have developed a promising mRNA-based immunomodulatory
approach (ACT), which shows efficacy of reducing α-syn pathology burden in a preclinical model. We also show
that ACT restores the lipidome to normal levels and hence visualizing the inter-brain distribution of lipids along
with key enzymes involved in lipid metabolism would help comprehend their roles and alterations over time in
the aging and diseased brain.
Systems biology approaches provide a holistic examination of interactions between the metabolome, and
environment in an attempt to comprehend pathomechanisms involved in LBDs. Imaging mass spectrometry
(IMS) is a new technology that has the ability to map a wide range of small molecules with high spatial resolution,
and the ability to quantify them, without a priori labeling, and hence can be harnessed to elucidate the role of the
metabolome in driving neurodegeneration. Here we propose to generate a spatial atlas of the lipidome to identify
lipid markers of disease progression in Aim 1, and assess lipid alterations resulting from ACT using MSI in Aim
2.

Public health relevance
PROJECT NARRATIVE Debilitating conditions such as Lewy body dementias (LBDs) belong to a spectrum of disorders that currently have no available disease modifying therapies. Recent studies point to the role of dysregulated lipid metabolism in LBDs, and developments in imaging mass methods enable the in situ analyses of lipid species in mouse brain tissue samples. The present study uses matrix-assisted laser desorption/ionization imaging mass spectrometry (MALDI-IMS), for direct anatomical analysis of lipid alterations as a function of time in brain sections from preclinical models of LBD, to determine lipid profiles from disease, non-disease controls, and animals treated with immunotherapy, which restores lipid homeostasis, to draw robust conclusions about lipid alterations in the course of LBD and after application of therapeutic intervention.